Effect of ambient heat on chronic kidney disease and end-stage kidney disease among US veterans

Project Summary
Chronic kidney disease (CKD) poses a significant health burden for the US population: 15% of the US adults,
or 37 million people, are estimated to have CKD. Among CKD's modifiable environmental risk factors,
exposure to high ambient heat has been linked to nephropathies in the US and globally, particularly in the
context of global climate change. Our current understanding of the effect of heat exposure on nephropathies
among the US population is limited, as we have only data on extreme heat exposure on acute kidney damage
and mortality from the emergency room or hospital visits. This application aims to evaluate the relationship
between ambient heat and new-onset CKD, its progression to end-stage kidney disease (ESKD), and the
underlying pathophysiological pathways in a large-scale nationwide cohort who had no kidney disease. We will
link spatiotemporally link the gridded Parameter-elevation Relationships on Independent Slopes Model
(PRISM) dataset of metrological variables with the health outcomes of the Racial and Cardiovascular Risk
Anomalies in CKD (RCAV) cohort of the VA population to accomplish our goal. We plan to use logistic mixed-
effect regression with cubic regression splines to determine the association between lagged ambient
temperature with incident CKD and ESKD, and causal mediation analyses to explore the biomarkers' mediated
effects of significant pathophysiological pathways. Our proposal will disentangle the role of ambient heat on the
new development and progression of nephropathies and increase our understanding of the mechanistic
pathways of ambient heat-related nephropathies ─ an emerging public health threat to the US and global
communities. Our results will positively impact designing heat adaptive interventions by clinicians, public health
managers, and the general public, as we will likely live with a higher number of days with increased ambient
heat in the future in a changing climate.

Public health relevance
Project Narrative Our planet Earth is warming. The exposure to higher ambient temperatures is increasing among the US population in major US cities and will continue to soar in the future. Evaluating the health burden of high ambient heat is directly related to the National Institute of Environmental Health Sciences' mission. This project will generate important evidence to understand the high ambient heat-induced chronic kidney disease development, progression, and pathophysiology among the US population, which will help in designing climate-adaptive strategies to protect population health.